JSU- Mississippi Delta Research Center of Excellence for Maternal Health

PROJECT SUMMARY: Research Project 2 - Empowering Women for Postpartum Care and Reproductive
Health in the Mississippi Delta
Maternal mortality and morbidity remain unacceptably high across the United States, and particularly in the
Mississippi Delta, with Black women experiencing an elevated and unjust risk of loss of life and health.
Evidence supports that engagement in healthcare across the pre- and postpartum continuum can reduce
adverse maternal outcomes. However, barriers to engagement in maternal healthcare persist in the
Mississippi Delta, despite many attempts to intervene. Legacies and current practices of structural and
interpersonal racism have led to distrust of health advocates and healthcare providers among Black women
and their families. Poverty, transportation, lack of health insurance, poor health literacy, and limited availability
of healthcare also contribute to health inequities. To improve access to care and quality of healthcare
services, these structural and interpersonal barriers must be acknowledged and addressed in a
comprehensive manner. In this research project, we propose a multisectoral patient-clinical linkage
intervention to increase comprehension, trust, and engagement in postpartum healthcare among parents in
the Mississippi Delta, with a specific focus on Black women, their families, and their communities. The
intervention will directly address structural and interpersonal barriers to engagement in postpartum healthcare
through (a) improving health literacy and communication skills among community health workers and licensed
clinicians (focusing on skills, written text and oral communication, tasks and activities for services utilization,
and the environment for provision of health services); (b) community health worker care coordination to
facilitate pre- and postpartum visits; and (c) employing strategies to increase insurance utilization postpartum
and defray the costs of attending care. These interconnected research activities aim to reduce structural and
interpersonal barriers to healthcare engagement, thereby empowering postpartum women to seek, advocate
for, and receive the healthcare they deserve. This research project will implement and evaluate the proposed
intervention through the following aims: (1) refine and implement the community-based patient-clinical linkage
intervention and evaluate its effectiveness in increasing maternal health engagement in medical care; (2)
evaluate the effectiveness of the community-based patient-clinical linkage intervention in improving health
literacy and increasing trust; and (3) evaluate the effectiveness of the community-based patient-clinical linkage
intervention in improving reproductive autonomy among postpartum parents in the Mississippi Delta. By
providing concrete support to access information and care, we will connect parents at high risk for adverse
maternal outcomes to quality preventive services. Ultimately, this research project will support the overall
mission of the JSU- Mississippi Delta Research Center of Excellence for Maternal Health to empower
women through increased trust and health literacy while reducing maternal morbidity and mortality in
partnership with the Mississippi Delta community.

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal aims to establish the Jackson State University (JSU) - Mississippi Delta Research Center of Excellence for Maternal Health to address preventable maternal mortality, decrease severe maternal morbidity, and promote maternal health equity in partnership with the Mississippi Delta community. This research center will conduct two multi-layered research projects utilizing community health partners, inclusive of an extensive research training program for early-stage investigators, to address the interpersonal and structural factors that affect maternal outcomes. By establishing an equal partnership with the community in all parts of the process, we envision that this research center will overcome structural and interpersonal barriers to high-quality, culturally competent postpartum maternal care and ultimately improve maternal morbidity and mortality for women residing in the Mississippi Delta.